Disease mechanism and genetic therapy for a pathogenic STXBP1 variant

PROJECT SUMMARY
STXBP1 encodes syntaxin-binding protein 1, an essential protein for presynaptic neurotransmitter release.
Patients with heterozygous pathogenic variants in STXBP1 are characterized by intellectual disability, epilepsy,
movement, and psychiatric disorders, which are collectively termed STXBP1-encephalopathy (STXBP1-E).
STXBP1-E is among the most common and severe forms of developmental and epileptic encephalopathy. The
current treatments at best only alleviate individual symptoms without targeting the underlying genetic defect.
Haploinsufficiency has been clearly identified as the disease mechanism for patients with truncating variants,
which is supported by multiple in vivo mammalian models that recapitulate neurological phenotypes of patients.
In contrast, the mechanism of action for missense variants, which make up 48% of the STXBP1-E patient
population, remains unclear, in part due to the lack of in vivo mammalian models with construct and face validity.
This leaves a critical knowledge gap in understanding the disease mechanism and developing mechanism-based
genetic therapies. Thus, there is a critical need to establish a mouse model of STXBP1 missense variants to
address this gap. To this end, the applicant focused on one of the most common and understudied missense
variants in STXBP1 and has established a knock-in mouse model that recapitulates all key aspects of disease
including epilepsy and impaired motor and cognitive functions. The goal of this project is to use this mouse model
to understand the molecular and synaptic mechanisms (Aim 1) and determine the efficacy of an adeno-
associated virus (AAV)-based gene therapy in rescuing the neurological dysfunctions (Aim 2). The applicant will
use genetic manipulations in combination with various techniques including biochemistry, electrophysiology,
optogenetics, behavioral assays, and electroencephalography (EEG) recordings. The proposed research is
expected to elucidate how a common missense variant contributes to neurological phenotypes in a mouse model
of STXBP1 encephalopathy and determine the potential of gene therapy as a therapeutic option. Furthermore,
this project is designed to prepare the applicant for a career as an independent scientist in research and
development and furthers the applicant’s long-term goal of performing gene therapy research to reduce the
burden of neurological disease for all people. The Sponsor, Dr. Mingshan Xue, has a strong track-record of
successful trainees and his lab conducts impactful research using mouse models of neurodevelopmental
disorders to discover disease mechanisms and genetic therapies to treat the disease. Furthermore, the
collaborative training environment of both Baylor College of Medicine and the Jan and Dan Duncan Neurological
Research Institute provides state-of-the-art technology cores, experts in the field of neurological disorders, and
a central location in the Texas Medical Center that facilitates the success of the project and training of the
applicant.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it seeks to understand the mechanism underlying a common missense variant in STXBP1 encephalopathy, and lack of knowledge about the mechanism underlying missense variants in STXBP1 has limited the ability to understand the pathogenic mechanism behind this disease. Furthermore, this project seeks to determine if adeno-associated virus-mediated gene replacement therapy can reduce neurological phenotypes in mice with a STXBP1 missense variant, and as current treatment options for STXBP1 patients are symptom specific and limited, this project presents the opportunity to establish a potential therapeutic for patients with missense variants in STXBP1. This project is applicable to the NIH’s mission because it will provide fundamental knowledge about the cellular mechanisms of intellectual disability and epilepsy, common symptoms across numerous neurodevelopmental disorders, and upon completion of this project, we will have an enhanced understanding about the brain and produce the ability to reduce the burden of neurological disease for people.